UC Irvine Center for Neural Circuit Mapping 2025 Conference: The Changing Brain

Project Summary / Abstract
The UC Irvine Center for Neural Circuit Mapping (CNCM) focuses on anatomical, functional and omics analysis
of neural circuits, and neurotechnology development. Our Center members are interested in defining molecular
and neural mechanisms that underlie neurodevelopmental, neuropsychiatric and neurodegenerative disorders.
We work collaboratively to establish transformative and translational research programs that focus on our
ultimate goal to develop cures for human diseases of the nervous system. The CNCM has become a hub for
cutting-edge technology and resource development in biomedical research. We disseminate our technology
resources in coordination with our educational and research initiatives such as seminars, symposiums, and
conferences. The 2025 summer conference “The Changing Brain” (August 18-21, 2025) jointly sponsored by
the CNCM, Cajal Club and Allen Institute for Brain Science will be held in Irvine, California, USA; this will be our
biggest conference yet with an increased focus on international reach. The 2025 meeting topics are timely and
significant. The Scientific Program Committee led by Dr. Liqun Luo at Stranford University, has planned six
sessions: 1) the Evolving Brain, 2) the Developing Brain, 3) the Learning Brain, 4) the Dynamic Brain, 5) States
of the Brain, 6) the Disordered Brain. Our confirmed speakers represent a distinguished roster of leading
researchers at various career stages in neuroscience. The speakers will offer diverse perspectives and in-depth
insights on the theme of integrating the different facets of neural circuits. We expect vibrant discussions ranging
from the latest technologies in neural circuit mapping to the implications of circuit dynamics in health and disease.
In addition to the main conference proceedings, attendees will have opportunities to participate in onsite
specialized workshops held on the UC Irvine campus. Workshops will offer more hands-on experiences that
allow for deep dives into specific subtopics and methodologies in conjunction with specific interests of the
attendees. Aligned to the NIMH mission, our meeting will promote the understanding and treatment of mental
disorders through basic and clinical research, and will support communication between scientists, physicians,
health-care providers, and the public about brain science advances and mental health research progress. We
will comply with the NIMH policy, and requested NIMH funding will facilitate the attendance of students, trainees
and members of underrepresented groups through waivered registration fees and travel awards.

Public health relevance
Project Narrative Following the success of our previous in-person conferences, the UCI Center for Neural Circuit Mapping is committed to organizing annual events focusing on neural circuit studies in health and disease. We expect that the 2025 conference will be a leading gathering in the neuroscience field, and our meeting will provide a formal forum to present and discuss new relevant research toward the understanding and treatment of mental disorders.